COCAINE, TOBACCO AND CAFFEINE USE BY WOMEN DELIVERING BABIES

To determine the prevalence of neonatal drug exposure, urine samples will be obtained on an anonymous basis from women delivering babies at SFGH and analyzed for metabolites of cocaine, tobacco, and caffeine. GCRC personnel will process samples and maintain the sample log to assure that blinding and confidentiality is maintained.